P30 - Core Grant for Vision Research

OVERALL COMPONENT
Project Summary
The main objectives of this NEI Core Grant for Vision Research is to support the study of the
visual system's structure, development, and function in both healthy and diseased states. The
ultimate goal is to prevent, alleviate, or cure vision-related diseases, as well as to restore lost
vision, by utilizing advanced techniques. This will be achieved through three resource and service
modules:
I. Ocular Structure and Function (OSF) module: This module will provide NEI R01 investigators
with the tools necessary for ocular phenotyping, including morphological analysis, light and
electron microscopy, ocular imaging, and functional vision testing. Additionally, it will offer
prototyping services.
II. Advanced Imaging and Analysis (AIA) module: The goal is to visualize cellular dynamics of
ocular tissues with high spatiotemporal resolution. This module will utilize state-of-the-art imaging
modalities, such as spinning disk, multi-photon, and confocal microscopes, along with resources
for quantitative image analysis and creation of visual content.
III. Vision Bioinformatics & Computation (VBC) module: This module focuses on advancing
vision research through bioinformatics and programming for customized research needs. VBC
will support the analysis of functional genomics datasets, including Next-generation sequence
(NGS) and "omics" data, and will establish custom-built software resources for advanced data
processing. VBC will provide computational resources and user-friendly software packages for
researchers of all levels of experience.

Public health relevance
OVERALL COMPONENT Project Narrative/Relevance Many blinding disorders affect millions of people of all ages. The UCSF Core Grant for Vision research application will facilitate studies of the structure, development and function of the visual system in health and disease, with the aim of preventing, mitigating or curing such disorders, or the restoration of lost vision or slow vision loss, through the application of the most sophisticated available techniques. Three resource and service modules are proposed to achieve these broad objectives, and the overall component proposes to serve and nurture the changing needs of our NEI R01 investigators and UCSF Vision research community by the following.